Investing in the Future: An Evaluation of Local Government Spending as a Modifiable Structural Determinant of Interpersonal Youth Violence

Project Summary/Abstract
I am an epidemiologist and Assistant Professor at UC Davis primarily studying the causes, consequences, and
prevention of firearm violence. My long-term career goal is to create a high-impact, methodologically rigorous
research program on firearm violence prevention. I am particularly interested in studying modifiable
upstream causes of violence that can be leveraged to effectuate widespread, enduring reductions in violence-
related harms. Aligned with this larger goal and the National Center for Injury Prevention and Control’s
interpersonal violence research priority of youth violence, the objective of the proposed study is to examine
local government spending as a potential structural determinant of interpersonal youth violence in the United
States. This will be accomplished through the following specific aims: 1) to determine whether city spending
on education, police, social services, and the community environment is associated with city rates of youth
violence; 2) to determine whether city spending on education, police, social services, and the community
environment is associated with Black-white racial disparities in city rates of youth violence; and 3) to
determine whether the ratio of city spending on policing to spending on the sum of other public goods and
services (education, social services, and the community environment) is associated with city rates of youth
violence. Secondary analyses will examine outcomes by race/ethnicity and firearm involvement to identify
race-based heterogeneity and firearm-specific trends. This will be a serial cross-sectional study of over 100
diverse cities in the United States, 1999-2018. It will draw on a novel dataset of city spending that has been
standardized to account for variation in the allocation of fiscal responsibilities to overlaying governmental
units (e.g., counties, school districts). Youth violence will be measured as victimization (homicide) and
perpetration (arrest for aggravated assault or homicide) among individuals between the ages of 10 and 24.
Sophisticated causal inference methods, including lagged fixed effects models and longitudinal g-
computation, will be used to minimize confounding bias and examine both short- and long-term associations.
This project will provide opportunities critical to my career development and research goals, including 1)
deepening my expertise of violence prevention and expanding into the subfield of youth violence, 2)
developing new methodological skills, and 3) moving toward research independence by serving as a primary
investigator. These training goals will be guided by my team of mentors and will be supplemented by
technical workshops offered primarily online. This proposal will be carried out at the Violence Prevention
Research Program at UC Davis, which has been engaged in firearm violence prevention research for more than
30 years. The proposed project will provide me the experience, skills, and support I need to advance my
research career and will allow me to substantially contribute to our limited understanding of the structural
determinants of violence.

Public health relevance
Project Narrative There is an urgent need to identify modifiable structural determinants of youth violence, as these “root causes” give rise to the material, social, and economic conditions that can promote or prevent violent acts. By examining the role that city investments in public goods and services play in youth violence, findings from this project will provide foundational knowledge about the structural determinants of youth violence and the racial disparities therein. This research will also provide actionable, policy-relevant findings to cities interested in achieving long-lasting reductions in violence through a strategic, health-oriented approach to spending.